Standardizing Antibiotic Prescribing for Children Hospitalized with Infections using Novel Metrics and Electronic Clinical Decision Support Tools

PROJECT SUMMARY/ABSTRACT
Antibiotics are one of the most prescribed classes of medications for children, yet 30-50% of all antibiotics are
inappropriately prescribed or completely unnecessary. Despite the availability of nationally endorsed treatment
guidelines and the expansion of antimicrobial stewardship programs, deviation from evidence-based practices
occurs adding to prescribing variability. Individual provider characteristics including knowledge deficits are
known to contribute to variability in antibiotic selection. However, other factors, including usability of available
prescribing resources, local culture, social pressures, and the work environment likely also contribute to this
variation, but have received less attention. Developing a rich understanding of sources of antibiotic prescribing
variability among front-line providers can inform usability and workflow integration to maximize uptake of
prescribing interventions. As mobile electronic clinical decision support (eCDS) tools have the potential to
reach broad audiences and to integrate the end-users (i.e., front-line prescribers) and user environment (i.e.,
busy inpatient ward) they may serve as powerful tools in the dissemination of evidence-based antibiotic
practices. Dr. Markham, a pediatric hospitalist physician and the candidate for this Career Development Award,
together with a strong interdisciplinary mentorship team has created a 5-year career development plan which
includes structured mentoring, completion of training in human factors science and the application of qualitative
methods within systems analyses, implementation science, and clinical informatics. This unique combination of
training activities in combination with Dr. Markham’s clinical expertise will place Dr. Markham at the forefront of
eCDS tool implementation in pediatrics. Acquisition of these skills will establish a pathway for Dr. Markham to
become a leader in addressing the quality and safety of pediatric hospitalizations through the development and
implementation of novel eCDS tools and interventions targeting other high-priority diagnoses affecting children.
Dr. Markham's training activities will be complemented by an innovative project that will facilitate practical
application of these new skills. The goals of the project are to: (1) measure and understand inter- and intra-
hospital antibiotic prescribing variability for children hospitalized with common infections; (2) utilize usability
testing and psychometric analysis to evaluate the impact of an eCDS tool to deliver evidence-based antibiotic
recommendations within simulated scenarios; and (3) perform a pilot implementation study to explore barriers
and facilitators to widescale deployment of a usability informed antibiotic eCDS tool. Findings from this study
will be used to prioritize infections in need of standardization of treatment, to track antibiotic standardization
improvement over time, and to inform future implementation studies examining the impact of eCDS tools on
standardization of antibiotic use and patient outcomes. The ultimate goal of this proposal is to provide Dr.
Markham with the skills to effectively enhance healthcare systems by improving the accuracy and efficiency
with which healthcare professionals can provide high-quality, evidence-based care to children.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it addresses inappropriate antibiotic use in children which occurs commonly and contributes to the development of antimicrobial resistance as well as individual adverse events and unintended consequences. Development of a rich understanding of antibiotic prescribing variability, a novel metric to track this prescribing variability, and a usability informed, mobile antibiotic electronic clinical decision support tool to impact this variability that is effective, efficient, and easily integrated into clinical settings offers the opportunity to substantially reduce inappropriate antibiotic use, ultimately leading to reductions in adverse events and unintended consequences in children. The proposed research is relevant to the Agency for Healthcare Research and Quality’s (AHRQ)’s mission for its focus on utilizing data and technology to improve healthcare quality and safety for children and adolescents, an AHRQ priority population.